The All-or-Nothing Marriage? Marital Functioning and Health Among Individuals in Same and Different-Gender Marriages

Project Summary/Abstract
Adult health in mid to later life in the US has been declining. Marital functioning is an important determinant of
adult health and wellbeing in different-gender couples, and changes to marital functioning over the past 40
years may be a critical mechanism underlying the US adult health decline. Scholars have argued that marital
functioning has declined over the past forty years, yet there is no research to support this claim. The recent
legalization of same-gender marriage for all means that the marital population has expanded and diversified in
ways scholars have yet to understand, and it is likely this population will grow as more same-gender
partnerships transition to marriage. Due to a lack of data and power, the associations between marital functioning and
health outcomes for individuals in same-gender marriages has received little attention. This project will identify
key changes in marital functioning and individual health and wellbeing in the U.S. over the past four decades in
different gender spouses, and benchmark these for same-gender spouses. Our approach will be to generate a
third repeated cross-section (i.e. a third wave) of the Work and Family Life Study data, complementing and
extending cross-sectional data collected in 1980 and 2000. We propose: Aim 1. Identify age, period, and cohort
trends in marital functioning (e.g. marital happiness and conflict, divorce proneness) over the past 40 years
among different gender spouses, and test for race and social class differences. Aim 2. Examine age, period,
and cohort trends in the association between marital functioning and adult physical and mental health over the
past 40 years among different gender couples, by race and social class. Aim 3. Examine the association
between marital functioning and adult physical and mental health in individuals in same-gender marriages by race
and social class, and compare the magnitude of these associations with individuals in different-gender
marriages. To examine Aims 1 and 2, we will collect a third cross-section of data of the Work and Family Life
Study, approximately 40 and 20 years after the first and second cross-sections. Population-representative data
will be collected from 2000 individuals, ages 18 to 55, in different-gender marriages. To examine Aim 3, we will
collect data from 300 women and 300 men in same-gender marriages. Data will be collected via phone and
online. The primary significance of this project is 1) evidence that marital functioning has declined over the past
40 years, and the identification of declining marital functioning as a mechanism underlying declines in adult
physical and mental health, and 2) the establishment of an association between poor marital functioning and
poor physical and psychological health and health behaviors in same-gender marriages across race and social
class. The proposed research is innovative because 1) it is a substantial departure from available U.S. data on
marital functioning and health across cohorts and periods for different-gender spouses, and 2) it will
benchmark marital functioning and health for married sexual minorities in the US. These data, the largest population-
based sample of individuals in same and different-gender marriages to date, will be available through ICPSR.

Public health relevance
Project Narrative The proposed research is relevant to public health because we will be identifying marital functioning change as a mechanism underlying adult health declines in the US, testing the role of adult poor health as a mechanism underlying marital functioning declines, and determining the association between marital functioning and health for individuals in contemporary same-gender marriages by race and social class, all of which is ultimately expected to lead to new evidence-based interventions and policies designed to improve adult health and wellbeing across American marital contexts. Overall, the primary positive impact will be evidence that will be used in efforts in clinical and community settings to facilitate successful health trajectories among individuals in different-gender and same-gender couples. Thus, the proposed research is relevant to NIA’s mission to better understand the effects of interpersonal relationships on aging, and the mechanisms through which they exert their effect, so that all Americans can have lives, and marriages, that are healthy, gratifying, and long.